Role of fibroblasts in bladder mucosal function

Although the viscoelastic properties of the bladder wall depend on it, and large numbers of
patients suffer from diseases that give rise to stiff, fibrotic bladders (e.g., neurogenic bladder,
outlet obstruction, underactive bladder, radiation cystitis), we know little about the bladder's
connective tissue including its constituent fibroblasts. We recently reported that the PDGFRA
(platelet derived growth factor alpha)-expressing “interstitial cells” of the mouse bladder are
fibroblasts, and that multiple, regionally distinct populations of these cells are found in the bladder
wall. One of these populations, the suburothelial fibroblasts (SUFs), reside in the lamina propria
just underneath the urothelium. They have a classical fibroblast-like ultrastructure, and they can
be differentiated from other bladder fibroblasts by the selective expression of ACTA2 (smooth
muscle actin), MYH9 (non-muscle myosin IIA), and MYH10 (non-muscle myosin IIB), along with
several other canonical and universal fibroblast markers. Strikingly, we observe that SUFs are
contractile, and that diphtheria toxin (DT)-mediated ablation of them leads to an underactive
bladder phenotype. Our studies will test the hypothesis that SUF-mediated contraction of the
lamina-propria associated collagen matrix promotes rugae re-formation after voiding, and that
afferent nerve processes distributed within and attached to the lamina propria collagen become
activated as the collagen fibers in the rugae unfurl, relaying information about the state of bladder
filling to the CNS. In Subaim 1.1 we will use conditional SUF Piezo1 knockout (KO) mice to
determine whether SUF-mediated rugae formation is dependent on the mechanosensitive ion
channel PIEZO1. In Subaim 1.2 we will use conditional SUF Itgb1 KO mice to determine if SUF-
collagen interactions are necessary for the post voiding formation of rugae. In Subaim 2.1 we will
assess whether SUFs are integral to mucosal contraction, collagen organization, and bladder
function in SUF-DT ablated mice or conditional SUF Piezo1 KO and Itgb1 KO mice. In Subaim
2.2, we will determine the contribution that mucosal unfolding makes to bladder afferent outflow
using SUF ablation and conditional deletion of Itgb1 in SUFs and sensory neurons. Impact: Upon
completion of our studies, we will have defined the molecular machinery that allows SUFs to refold
the mucosa into rugae when the bladder empties and established a novel role for rugae in
regulating bladder afferent signaling and function as the bladder fills.

Public health relevance
The inner lining of the urinary bladder is covered with mucosal rugae that unfurl during bladder filling, but how they re-form after voiding and their purpose is not well understood. Our studies will define how contraction of a specialized population of suburothelial fibroblasts regulates rugae formation, and then determine how unfolding of these rugae contributes to afferent nerve signaling and bladder function.